Interstitial Photodynamic Therapy Following Palliative Radiotherapy for Patients with Inoperable Malignant Central Airway Obstruction

Summary
Patients with extrabronchial tumors that induce malignant central airway obstruction (MCAO) face significant
morbidity and only 1-7 months median overall survival. An estimated 20-30% of patients with lung cancer will
have MCAO during the course of their disease, but other malignancies that metastasize to the airway can induce
central airway obstruction. We have recently reported, in a Phase I study, that Photofrin® mediated image-
guided interstitial photodynamic therapy (I-PDT) with our novel treatment planning and light dosimetry platform
is safe, with promising outcomes. Three out of 10 treated patients are alive at 26.5, 12 and 8.3 months. Our
image-based treatment planning was used to guide the administration of the light dose rate (irradiance) and light
dose (fluence) to the target tumor while sparing adjacent normal tissue.
Our goal is to improve the rate of complete and partial tumor response of extrabronchial MCAO to I-PDT. To that
end we propose to increase tumor blood oxygenation that will increase laser light transmission and oxygen
supply known to improve the efficacy of PDT. Murine studies reported that palliative x-ray radiotherapy (p-XRT)
can increase tumor oxygenation and alter vasculature. We therefore explore the use of p-XRT to improve tumor
response to I-PDT. Our preliminary data demonstrate that p-XRT followed by I-PDT (p-XRT/I-PDT) significantly
increases (p<0.05) complete response of locally advanced mouse tumors, in comparison to either I-PDT or p-
XRT. Under compassionate care exemption we showed that I-PDT delivered 48 ± 4h after 8Gy x1 p-XRT can
provide control of extrabronchial MCAO in two patients. There are no effective treatments for extrabronchial
MCAO. Thus, the overriding significance of our proposal is its responsiveness to an unmet clinical need.
We hypothesize that standard of care p-XRT (8Gy x1) followed by I-PDT is safe and will improve treatment
outcomes in patients with extrabronchial MCAO, and that this improvement is due to changes in the
tumor microenvironment. To test our hypothesis, we propose to accomplish the following aims.
Aim 1. To conduct a Phase I/II study to test the safety and efficacy of p-XRT followed by I-PDT in patients
with extrabronchial MCAO. We define success as demonstrating that this treatment is safe and result in ≥50%
of participants having partial or complete tumor response and/or significant improvement in quality of life and
physical performance at 3 months post treatment. We will
transmission and immune markers with tumor response.
evaluate the relationship of changes in light
Aim 2. To define the mechanisms by which p-XRT improves tumor response to I-PDT in mouse models.
We will define how changes in tumor microenvironment impact light transmission and tumor response, as well
as the contribution of anti-tumor immunity to tumor control and tumor-free survival.
These data will inform the design of a future randomized Phase II trial of p-XRT/I-PDT versus standard of care.

Public health relevance
Project Narrative The goal of this project is to improve treatment outcomes for patients with external locally advanced cancer that causes airway obstructions. These patients are not candidates for surgery and have no effective treatments. We propose that patients will benefit from a promising combination of interstitial photodynamic therapy with low dose radiotherapy that preliminary data show to safely ablate tumor and improve survival.